Immune control of chronic viral infection in solid organ transplantation

ABSTRACT
Immunosuppression required for lifesaving solid organ transplantation is complicated by significant
morbidity including increased recurrence of latent viral infection in transplant recipients. Approximately
60-70 percent of adults in the United States are latently infected with Cytomegalovirus (CMV). Control of
latent CMV depends on a continuously active immune response. In both healthy individuals and
immunocompromised transplant recipients, latent CMV has a profound effect of shaping the T
lymphocyte repertoire. We previously showed that the combination of immunosuppression and latent
CMV is sufficient to induce “accelerated” aging in the T cell compartment during the first year after kidney
transplantation. Immune aging or immunosenescence diminishes the capacity to respond to infection
and vaccination. However, whether the acceleration of aging continues to occur after the first year and
whether it is confined to the T cell compartment has not been studied. Our preliminary data suggests a
rapid aging of the B cell compartment over the first 2 years post-transplant as well as poor antibody
responses to vaccination in those with latent CMV. In this renewal, we hypothesize that latent CMV
continually shapes and ages the immune system in an accelerated manner after transplantation resulting
in diminished heterologous immune responses. Using a network of VA transplant centers and an
experienced team of transplant physicians and scientists, we will test this hypothesis with the following
specific aims: 1) determine the effect of latent CMV on immune aging in the B cell compartment, 2)
determine if accelerated inflation and aging continues after the first-year post- transplantation
and 3) determine whether immune changes induced by latent CMV can be used as predictors of
successful responses to SARS-CoV-2 booster vaccination responses. Results from these studies
will substantially expand our understanding of fundamental changes to the immune system induced by
CMV in the setting of solid organ transplantation thus providing critical knowledge that will aid in the care
of this at-risk Veteran population.

Public health relevance
End stage disease of the kidneys, heart, lungs, or liver shorten the lives of veterans and solid organ transplantation of these organs is life saving. Transplantation requires life-long medications that reduce the function of the recipients’ immune systems. These medications are needed to keep the recipient from rejecting and losing the transplant, but also cause several complications including what are termed opportunistic infections. Cytomegalovirus or CMV is a virus that 60-70% of the population is infected with at a young age and is never cleared, but rather is kept in check throughout life by an active immune system. In settings of reduced immune system such as after transplant, CMV can recur resulting in illness including loss of the transplant or even death. Even when suppressed, CMV has profound effects on the immune system. This proposal seeks to better understand both the immune response to CMV and alterations to the immune system caused by CMV in veteran transplant recipients with the eventual goal of improving the lives of these patients.